Pitt Integrated Clinical and Geroscience Research Training Program

ABSTRACT
This is the third competing renewal of the Pitt Integrated Clinical and Geroscience Research Training Program
T32. Our overarching long term goal is to produce a new generation of investigators with a background in
collaborative clinical, translational and the biology of aging methodology who have the enthusiastic
commitment, knowledge and skills to succeed in a career in integrated clinical and geroscience research. Our
program is one of only a few in the nation that focuses on individuals who will be trained in an environment that
integrates a clinical and biological perspective. The University of Pittsburgh offers an outstanding milieu for this
training, with exceptional depth and breadth of multidisciplinary aging research; experienced, involved and
well-funded mentors and extensive resources for training in clinical, translational and biology of aging research.
The comprehensive training program is built on a well-defined structure with five main areas of competence: 1)
core competency in clinical, translational and biology of aging research methods, 2) collaborative team
mentoring techniques and methodology, 3) professional skills, 4) topical expertise and 5) responsible conduct
of research. To achieve competence in these areas we employ the following training strategies: 1) an individual
career plan, 2) formal didactics, 3) seminars and workshops, 4) an individualized, integrated mentoring team
including clinical and basic scientists, and 5) scheduled oversight and mutual feedback. The training program
focuses on two levels of trainees; 1) a 2-3 year postdoctoral program for physician investigators and
postdoctoral fellows, and 2) a 2 year predoctoral MD/PhD training program for medical students that is
integrated into the University Of Pittsburgh School Of Medicine Medical Scientist Training Program.

Public health relevance
NARRATIVE This is the third competing renewal of the Pitt Integrated Clinical and Geroscience Research Training Program T32. Our overarching long-term goal is to produce a new generation of investigators with a background in collaborative clinical, translational research and the biology of aging methodology who have the enthusiastic commitment, knowledge and skills to succeed in integrated clinical and geroscience research. Our program is one of only a few in the nation that focuses on individuals who will be trained in an environment that integrates a clinical and biological perspective. The training program focuses on two levels of trainees: 1) a two year postdoctoral program for physician investigators and postdoctoral fellows, and 2) a 2-3 year predoctoral MD/PhD training program for medical students that is integrated in the University of Pittsburgh School of Medicine MD/PhD Medical Scientist Training Program.